Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY
The overall goal of the Administrative Core is to provide direction, guidance, and oversight for the PCEN and
assure its effective and efficient functioning. The Administrative Core will facilitate the work of the two Biomedical
Research Cores, the Learning Health System Core (LHS Core) and the Molecular Precision Nephrology Core
(MPNC), and support the Enrichment Program, Opportunity Pool Pilot and Feasibility Program, and two
Research Projects. The Enrichment Program aims to equip the research base with additional skill sets and
maximizes interactions and intellectual discourse within the PCEN. Initiatives within the Enrichment Program will
encourage and support innovative multidisciplinary research in pediatric kidney disease through early career
engagement, including the Summer Scholar program; career development and collaborations; and patient,
family, and community engagement. The Opportunity Pool Pilot and Feasibility Programwill continue to stimulate
and solicit new project ideas to address key barriers to research progress in pediatric nephrology, specifically for
early stage investigators, new investigators, or established investigators not previously involved in research on
pediatric kidney disease. The CHOP PCEN organizational structure includes oversight by an External Advisory
Board (EAB) and input and guidance from a Scientific Advisory Committee (SAC). The Steering Committee will
set overall policy for the CHOP PCEN and will include the Center Co-Directors, the SAC Chair, the Biomedical
Core Directors and leadership, and the ProgramLeads. In addition to facilitating collaborations across the CHOP
PCEN collaborators at CHOP, the University of Pennsylvania, and Johns Hopkins University, the Administrative
Core will support interdisciplinary partnerships across the CHOP PCEN research base and the PCEN Network.
Our team includes individuals with proven track records in mentoring, basic science, translational research,
clinical investigation, epidemiology, informatics, and health services research. We will build upon the success of
our established PCEN to expand the evidence base of observational data for clinical trial design and enhance
the infrastructure for pragmatic clinical trials and comparative effectiveness through the LHS Core; facilitate the
identification of novel therapeutic targets through the MPNC; foster collaboration in kidney disease research
across other centers; and mentor members of the broader nephrology community by supporting the Enrichment
Program, an Opportunity Pool Program, and innovative research projects in childhood kidney disease.